Investigate The Impact of Third-Hand Smoke on Platelet Function and Thrombogenesis

Thirdhand smoke (THS), the persistent residue of tobacco smoke that remains after a cigarette is
extinguished, materialized as a threat for human health over the last decade. There is growing body of
evidence documenting THS-induced health risks, including cardiovascular disease (CVD). Nonetheless, there
remains skepticism regarding THS existence, and much less is known or has been investigated with regard
to its toxicity. The goal of my research studies is to investigate the mechanistic impact of THS exposure
and its toxicants in the context of platelet function, and whether sex plays any role in these effects.
Two specific aims are proposed:
Specific Aim 1. Investigate the impact of THS-exposure on platelet-dependent disease states. This aim
will investigate the consequences of exposure to THS on platelet dependent disease states. In light of the
fact that hyperactive platelets result in a prothrombotic state, subsequent studies will, similarly, examine
whether THS participates in the development of thrombotic disorders. Finally, given that the coagulation
system may contribute to the THS phenotype, its effects on plasma levels of thrombosis markers (e.g.,
thrombin), TAT and other elements will also be examined. These studies will be conducted in a dose-, time-,
and gender-dependent fashion, given the importance of these issues for understanding the THS effects.
Specific Aim 2. Investigate the mechanism by which THS-exposure modulates platelet function. This
aim will investigate the ability of THS exposure to enhance platelet function, spreading, calcium homeostasis,
biochemical markers of platelet activation, isoprostanes levels, and whether effects are receptor mediated.
We will also determine the major route of THS exposure, all of which in a dose, time and sex dependent
manner.

Public health relevance
Collectively, the experiments presented in this supplemental funding request, and the training plan are designed to develop a minority postdoctoral fellow, namely Dr. Daniel Villalobos as a future scientist. The studies, some of which are translational in nature, address fundamental and mechanistic concerns regarding the cardiovascular health effects of the newly discovered form of tobacco exposure, by employing a systematic platelet function and related animal model and disease analysis approach. The training and the results obtained should develop his critical thinking and scientific writing skills, as well as promote further smoking cessation, as well as lay down the foundation for understanding, and advancing policy and means for evidence-based therapeutic management, prevention and control efforts of tobacco-associated thrombosis-based disease states.